DELTA Q Mass Spectrometer

Project Summary/Abstract
We are seeking to acquire a Delta Q Isotope Ratio Mass Spectrometer (IRMS) along with its peripherals for the
UW Isotope Ratio Laboratory. The need for this instrument arises because our current Delta Plus and Delta V
instruments are obsolete and no longer, or soon to be no longer, supported by the manufacturer and pose
extreme challenges in terms of operability and repairs. The upgraded Delta Q IRMS is a versatile and high-
performance instrument that accurately measures stable isotopic ratios in both gaseous and solid samples. Its
enhanced capabilities and efficient sample analysis per isotope will ensure the continuity of our lab's operations.
Specifically, this instrument will play a vital role in measuring stable isotopic ratios of hydrogen and oxygen, with
a specific focus on doubly labeled water studies. These studies are of utmost importance in the fields of nutritional
sciences and obesity research. The precise measurements and advanced technology of the Delta Q IRMS will
provide reliable data for investigating energy balance components, thus making a significant impact in the obesity
field. Accurately measuring energy intake and expenditure is crucial for comprehending human energy balance,
and the doubly labeled water method stands out as the most precise approach for this purpose [1]. Conventional
methods that rely on self-reported data through diet records and questionnaires are susceptible to errors and
bias[2], while the doubly labeled water method, coupled with changes in body energy stores, has been advocated
by Ravelli and Schoeller, 2021 [3]. As a result, the doubly labeled water method, which relies on isotope ratio
analyses, is indispensable for understanding energy balance, preventing obesity and chronic diseases, and also
addressing malnutrition [4]. Access to isotope ratio analyses is limited to a few expert labs worldwide, and our
lab has been at the forefront of pioneering the doubly labeled water method for the past 25 years [5]. We have
provided analyses to 28 investigators leading to 107 publications, which have been cited more than 47,000 times.
To continue meeting the demands of our NIH-funded users, the acquisition of the Delta Q IRMS is indispensable.
It will (1) provide precise and accurate isotopic ratio measurements, enabling in-depth exploration of energy
expenditure, energy intake, body composition, and metabolic pathways in humans and animals, (2) enhance the
health-related goals of our users' investigations, and (3) foster biomedical research within and beyond our
institution. The acquisition of this instrument is vital for cutting-edge research and its availability in the UW Isotope
Ratio Lab will have a profound impact on the scientific community. Ensuring the continuous generation of
accurate data will enable valuable insights and advancements in diverse research areas that rely on stable
isotope analyses. Moreover, it will empower researchers to make significant strides in various health-related
fields. This instrument plays a crucial role in advancing scientific knowledge and fostering innovation ultimately
contributing to breakthrough discoveries. In light of these considerations, we request the acquisition of a shared
Delta Q IRMS to support our services to users and contribute to advancements in obesity and other fields.
S10: Isotope Ratio Mass Spectrometer for UW Bioanalytical Isotope Ratio Laboratory

Public health relevance
Project Narrative Involuntary weight gain or weight loss can lead to individuals becoming underweight, overweight, or obese, often indicating an inadequate response to acute health issues or the onset of chronic diseases. To comprehend the underlying causes and develop effective treatments, it is crucial to measure parameters such as energy expenditure and energy intake accurately. This can be achieved through the use of stable isotope tracer technology in combination with isotope ratio mass spectrometry, providing precise measurements for a comprehensive understanding of these phenomena. S10: Isotope Ratio Mass Spectrometer for UW Bioanalytical Isotope Ratio Laboratory